DCCPS - NCCR Data Platform Supplement

The purpose of the NCCR Data Platform project is to bring together key information on every childhood cancer patient regardless of where or when they receive care and will support research about childhood cancer patients and survivors. Leidos Biomed provides biomedical informatics support to the NCCR to support this mission. More specifically, Leidos will provide a subject matter expertise (SME) in biomedical informatics to support the development, deployment, enhancement and maintenance of the information systems. The SME will provide important guidance and connections between various technical teams developing the NCCR data platform utilizing their understanding of the underlying technical requirements to achieve the desired functionality of the platform.